Nociplastic mechanisms in somatic and visceral pain

PROJECT SUMMARY/ABSTRACT
Chronic pain is a significant social and economic burden. Despite considerable progress over the last several
decades of research, our understanding of the neurobiological underpinnings of chronic pain remains
incomplete and this presents obstacles for improvement in pain management. Multimodal investigations into
the mechanistic heterogeneity within and across chronic pain conditions are critical for the development of new
and efficacious precision pain treatments.
The central nervous system (CNS) governs the perception of pain. Sensitization of the CNS is a mechanism
hypothesized to underly the increased pain and sensory sensitivity observed in patients with chronic pain. This
mechanism is referred to as nociplastic pain. Quantitative sensory testing (QST), functional magnetic
resonance imaging (fMRI), and patient-reported outcome measures (PROMs) are methods that can be used
together to build multimodal profiles that characterize the degree and features of an individual’s nociplastic
pain phenotype. The proposed F99 and K00 projects will use these methods to distinguish convergent and
divergent nociplastic mechanisms across diagnostically distinct somatic (emanating from bones and soft
tissue) and visceral (emanating from internal organs) chronic pain conditions.
The overall objective for the proposed project is to identify shared and distinct nociplastic profiles between
somatic and visceral pain conditions to ultimately stimulate the development of precision pain management
tools. The goal of the F99 portion is to characterize sensory and neurobiological features of nociplastic pain in
patients with somatic pain, including those with rheumatoid arthritis (RA), osteoarthritis (OA), and carpal tunnel
syndrome (CTS), relative to healthy controls and patients with fibromyalgia – the archetypal nociplastic pain
condition. This analysis will build a foundation for the long-term aim of this work’s K00 portion, where parallel
sensory and neurobiological measures will be assessed in patients with visceral pain, including those with
urologic chronic pelvic pain syndrome (UCPPS), overactive bladder (OAB), and gynecological chronic pelvic
pain (CPP). Data from the NIDDK-funded Multidisciplinary Approach to the Study of Chronic Pelvic Pain
(MAPP) Research Network and Lower Urinary Tract Dysfunction Research Network (LURN) will be leveraged
to complete the K00 project. Together, the mentoring and research activities of this F99 and K00 work will
establish a career trajectory for me to become an independent researcher with expertise in urological pain.

Public health relevance
PROJECT NARRATIVE Improving pain management is a critical need of the U.S. healthcare system. This project leverages quantitative sensory testing and brain imaging methods to identify key mechanistic similarities and differences across somatic and visceral pain conditions, including rheumatoid arthritis, osteoarthritis, and bladder pain syndrome. The fundamental knowledge drawn from these investigations supports the NIH mission to enhance public health by its potential to provide novel insights for pain treatment.